Research Program

PROJECT SUMMARY RESEARCH PROGRAM
The overarching goal of the JAX Cancer Center (JAXCC) Research Program, Genetic Models for Precision
Cancer Medicine, is to advance the vision of precision oncology through basic research discoveries with
potential for translational and clinical impact. Members use diverse, multi-scale strategies to deconvolute
complex cancer systems to their principal components and to investigate the drivers of cancer cell complexity,
tumor evolution, and tumor adaptation. Elucidating these fundamental biological processes are key to a
principled, mechanistic understanding of the adverse effects of cancer therapy and of treatment resistance.
During the current funding period we have expanded, and reshaped, the JAXCC into a new cancer research
force with a focus on complex genetics and functional genomics. Research is organized around three
complementary Specific Aims. Aim 1 seeks to develop novel organismal, cellular, and computational models of
cancer, drawing on the JAXCC's longstanding strengths in model development. Aim 2 examines the genomic
instability and genetic complexity of cancer and determines their functional consequences in the cancer cell.
Using advanced computational methods and genomic technologies we will interrogate animal models developed
in Aim 1 as well as patient samples. Aim 3 investigates how key components of a tumor and the host contribute
to cancer biology, examining the cancer cell intrinsic and extrinsic components of a malignant tumor. Results
from studies in Aim 3, integrated with the genetic alterations identified in Aim 2 with models developed in Aim 1,
will allow us to deconvolute the complex interactions of the tumor and host microenvironments. The 53 full
program members of the JAXCC include 33 on the Bar Harbor campus and 20 on the Farmington campus.
Through its emphasis on basic research, unique model development, and technological innovation, the program
leverages funding from multiple NIH ICs in support of cancer-focused research. More recently, we brought our
technologies into the clinical arena through collaborations with SWOG, the Maine Cancer Genomics Initiative,
City of Hope, Beth Israel Deaconess Medical Center, University of Connecticut Health Center, and the
Connecticut Children's Hospital. The program is supported by $10,401,511 direct costs in NCI and other peer-
reviewed cancer-related grants in the last budget year. Over the last grant cycle, CCSG funds have supported
379 publications including 30% intra-programmatic collaborations and 72% with external collaborators. The
efforts of the Co-Program Leaders, Drs. Karolina Palucka and Roel Verhaak, and JAXCC leadership have
fostered interactivity among JAXCC members through regular Research Program meetings, subsidized travel
between campuses, and the JAXCC Annual Retreat. The annual JAXCC Retreat and monthly program meetings
are the primary forums that bring together Cancer Center members from both campuses to develop intra-
programmatic collaborations and to participate in the planning for resource development and faculty recruitment.